Passive stretch of the chest wall in patients with Congential Muscular Dystrophy

DESCRIPTION (provided by applicant): Congenital muscular dystrophy (CMD) secondary to collagen VI deficiency is a distinct genetic neuromuscular disorder presenting from birth with progressive loss of motor function, skeletal deformities and debilitating contractures. Respiratory failure is the principal cause of morbidity and mortality from the disease. As CMD has no existing treatment, the majority of affected children develop respiratory failure and require non-invasive ventilation between the first and second decades of life. There is evidence that in muscular dystrophy the progressive decrease in lung volume is disproportionally greater than anticipated for the degree of respiratory muscle weakness. Chest wall stiffness and decreased lung elasticity which collectively diminish compliance of the respiratory system are believed to be important contributors to the disproportionate decrease in lung volume. Our research aims at testing the hypothesis that in subjects with CMD, daily passive stretch of the chest wall through lung hyperinsufflation therapy could slow down the annual rate of decline in lung volume, delay the onset of respiratory failure and improve quality of life. We will demonstrate that 1) By measuring in each subject the respiratory pressure volume relationship, maximum lung inflation by hyperinsufflation could be attained and the corresponding pressure estimated, 2) Subjects with CMD will be able to adhere to a twice-a-day 15 minute hyperinsufflation regimen over a period of 5 months and 3) Demonstrate that by studying for a period of one year 17 subjects enrolled in the intervention group and 17 in the observational group, the difference in the rate of decline of vital capacity between the 2 groups will yield an effect size of > 0.5. The results of this application will pave the way for the development of a future randomized control trial of daily passive stretch of the chest wall through lung hyperinsuflation in patients with neuromuscular disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: The development of respiratory failure in children with neuromuscular disorders is due in part to progressive stiffness of the chest wall and the lungs. In this application and in future research, we intend to test the feasibility and efficacy of passie stretch of the chest wall by lung hyperinsuflation on the onset of respiratory failure and the quality of life of patients and their care givers. (End of Abstract) __SpecificAimsTextDelimiter__ A. Specific Aims: Congenital muscular dystrophy (CMD) secondary to collagen VI deficiency is a distinct genetic neuromuscular disorder presenting from birth with progressive loss of motor function, skeletal deformities and debilitating contractures [1] [2]. Respiratory failure is the principal cause of morbidity and mortality from the disease [3]. As CMD has no existing treatment ([4], the majority of affected children develop respiratory failure and require non-invasive ventilation between the first and second decades of life [3]. The disease burden is further compounded by the high health care costs of patients with muscular dystrophy, which averages 10 to 20 times greater than individuals without muscular dystrophy [5]. There is evidence that in muscular dystrophy the progressive decrease in lung volume is disproportionally greater than anticipated for the degree of respiratory muscle weakness [6]. Chest wall stiffness and decreased lung elasticity, which collectively diminish compliance of the respiratory system, are believed to be important contributors to the disproportionate decrease in lung volume [7]. As such, it is likely that the loss of pulmonary function in CMD is due on the one hand to the progressive dystrophic process of the muscles, and on the other hand to secondary developmental and altered tissue characteristics of the chest wall and lungs. These secondary changes may in turn lead to the development of an acquired form of thoracic insufficiency that accelerates the onset of respiratory failure. While the progressive dystrophic course of the muscle disease cannot be modified yet with specific therapy, the secondary anatomical and functional effects on the respiratory system are potentially modifiable. Our research aims at testing the hypothesis that in subjects with CMD, daily passive stretch of the chest wall through lung hyperinsufflation therapy could slow down the annual rate of decline in lung volume, delay the onset of respiratory failure and improve quality of life. Several studies have attempted to adopt hyperinsufflation protocols in patients with neuromuscular disorders [8] [9]. However, neither the settings of a hyperinsufflation protocol nor its tolerability have been determined. The absence of a standardized protocol, which achieves passive stretch of the chest wall in CMD patients, hinders the investigation of a potential therapy targeting the anatomical and functional sequel of respiratory muscle weakness. In this study, we will test a personalized hyperinsufflation protocol that is titrated to individualized patient lung mechanics to achieve a tolerable passive stretch of the chest wall. Furthermore, the studies of pulmonary function in patients with neuromuscular disorders have relied on the measurement of vital capacity obtained by the standard forced exhalation maneuver named forced vital capacity (FVC). Our data suggest that a large percentage of neuromuscular patients are unable to perform FVC to American Thoracic Society (ATS) criteria, specifically duration of exhalation and reproducible maximum effort during the test. Guided by these data, this limitation will be overcome by measuring vital capacity by a slow exhalation maneuver (SVC) yielding a more reliable measure of lung volume that meet the ATS criteria in all patients enrolled in this trial. The current proposal will achieve the following aims through a randomized controlled design: Specific Aim 1: Demonstrate that by measuring the respiratory pressure-volume relationship in each subject, maximum lung inflation by hyperinsufflation will be reliably attained at the corresponding pressure. Through non-invasive delivery of incremental pressures, maximum lung inflation will be reached when volume begins to plateau on the pressure-volume curve. The optimum pressure will be defined as the lowest of 2-3 consecutively incremental pressures, which achieve volumes that are within 10% of each other, when the maximum tolerated pressure is reached or when a pressure of 35 cm H2O is attained. For each subject the final pressure will be estimated from 6 trials. Specific Aim 2: Demonstrate that subjects with CMD will be able to adhere to a twice-a-day 15-minute hyperinsufflation regimen over a period of 12 months. A personalized hyperinsufflation regimen will be prescribed based on results from Specific Aim 1. Adherence will be defined as performing e 80% of the treatments for the duration of the study. Daily Phone Diary (DPD), a validated tool in the pediatric rare disease arena adherence assessment will be used. Reasons for failure to adhere such as poor tolerance and adverse events will be collected. Specific Aim 3: Demonstrate that by studying for a period of one year 17 subjects enrolled in the intervention group and 17 in the observational group, the difference in the rate of decline of vital capacity between the 2 groups will yield an effect size of > 0.5. 34 subjects with CMD will be randomized to a control group that will only receive standard of care and an intervention group that will receive the daily hyperinsufflation in addition to standard of care.